Lifespan and Cardiovascular Health Effects on The Brain in Humans and Great Ape

Project Summary
Humans and great apes share many similarities in age-related illnesses including cardiovascular and
cerebrovascular diseases. Nevertheless, critical differences exist that may be key to understanding the
precipitous age-based cognitive decline observed in some humans that is less evident in apes. For instance,
humans can live nearly twice as long as the oldest recorded great ape. Additionally, despite being our closest
evolutionary relatives, the principal cause of heart disease differs between humans and great apes. The most
frequent type of cardiovascular disease in elderly humans is coronary artery disease due to atherosclerosis,
whereas great apes are highly prone to cardiomyopathy-associated heart failure. Why heart disease varies
between apes and humans and how it potentially relates to cerebrovascular disease and cognitive impairments
are important unanswered questions, which may shed light on the unique human vulnerability to these
pathologies that affect lifespan. Here, we will examine the impact of cardiovascular health on longevity, the brain,
and diseases of aging in humans and great apes including chimpanzees, bonobos, gorillas, and orangutans. In
Aim 1, we will evaluate the effect of aging, cardiovascular disease, and neurovascular health on the brains of
humans and great apes. Using stereology and electron microscopy, we will measure neuron and glial cell
densities, synapse and mitochondrial densities, and other age-related cerebrovascular pathology in humans and
great apes across their lifespans and in individuals with cardiovascular and cerebrovascular diseases.
Multiplexed immunofluorescence imaging of age- and cerebrovascular-related neuropathology (e.g., cerebral
amyloid angiopathy, Alzheimer’s disease lesions) also will be performed in each species. In Aim 2, the proposed
studies will identify and determine if age-related vascular risk factors are associated with cognitive impairment
in great apes. We will use archival MRI brain scans to identify potential volumetric changes associated with age
and cardiovascular and cerebrovascular diseases as well as evaluate for the presence of neurovascular-related
lesions, such as white matter hyperintensities. Furthermore, we will quantify white matter microvessel,
endovascular cell, and vascular length densities from humans and apes to investigate associations with age,
species, and disease status. We will investigate cellular localization of CD36, a protein involved in lipid
metabolism that may differ between species, in fixed postmortem brains from humans and apes. In Aim 3, our
studies will examine how age and cardiovascular health influence cognition in chimpanzees compared to
humans. This will include retrospective and prospective analyses between measures derived from transthoracic
echocardiograms with cognitive and motor function as well as several biomarkers of cardiovascular and
cerebrovascular diseases in chimpanzees. Taken together, outcomes from our proposed studies will provide
insights into how cardiovascular and cerebrovascular disease differentially contribute to the health, cognition,
and lifespan of apes and humans.

Public health relevance
Project Narrative With longevity setting them apart from other primate species, humans experience high rates of cardiovascular, cerebrovascular, and neurodegenerative diseases during aging. Older great apes also exhibit cerebrovascular abnormalities, neurodegeneration with Alzheimer’s disease-like pathology, and frequent mortality from heart disease, but lack atherosclerosis and neurotoxicity that are devastating to humans. The goal of the proposed studies is to examine the interrelationship between age-related changes in cardiovascular and cerebrovascular disease in humans and great apes as a means of understanding their impact on longevity and health as well as the unique susceptibility of humans to cognitive decline.